Exploring MicroRNAs as Predictors of Cervical Intraepithelial Neoplasia Outcomes

? DESCRIPTION (provided by applicant): Each year in the United States, ~250,000 women are diagnosed with low-grade cervical dysplasia. Due to the potential for adverse outcomes associated with reflex ablative therapy for low-grade dysplasia and the expectation that 2/3rds of these lesions will resolve on their own, most health care providers take a wait-and-see approach to managing low-grade dysplasia. This approach involves frequent repeat screening by cytology and/or colposcopy-directed cervical biopsies and creates a clinical conundrum: women with low-grade dysplasia that is destined to resolve endure unnecessary follow-up visits, medical procedures, anxiety, and healthcare costs, while intervention is delayed for women whose low-grade dysplasia is destined to progress to high-grade dysplasia or cervical cancer. Currently there is no clinical test that can reliably predict the outcome of low-grade dysplasia (natural resolution vs progression). This application investigates the potential of microRNAs (miRNAs) to serve as predictors of the fate of low-grade cervical dysplasia. The hypothesis is that microRNAs can be used clinically to predict progression of low-grade to high-grade dysplasia/cervical cancer. Two specific aims are proposed. First, candidate prognostic miRNAs will be identified by comparing miRNA expression profiles in women whose low-grade dysplasia resolved to the miRNA expression profiles in women whose low-grade dysplasia progressed, using archived clinical biopsy specimens. Second, the feasibility of using Pap smear samples as a surrogate to biopsy for miRNA testing will be ascertained. This research forms the foundation for the development of new screening tests that will inform management of low-grade cervical dysplasia.

Public health relevance
PUBLIC HEALTH RELEVANCE: Most cases of cervical intraepithelial neoplasia (CIN) - the precursors to cervical cancer - naturally resolve, and current cervical cancer screening tests cannot predict which CIN lesions will resolve and which will progress to cancer. This proposal evaluates the potential of molecular biomarkers known as microRNAs to predict the fate of CIN. The ability to predict CIN fate will improve cervical cancer screening programs by focusing health care resources on women with CIN that has the highest likelihood of progressing to cancer while sparing the majority of women with CIN from unnecessary interventions.